Rhode Island's Maintenance of its State Manufactured Food Regulatory Program

Grant Proposal Abstract
Title: Rhode Island's Maintenance of its State Manufactured Food Regulatory Program
Funding Opportunity Announcement Number (FOA): RFA-FD-23-027
The RI Department of Health (RIDOH), Center for Food Protection (CFP), proposes to maintain
and sustain a risk-based manufactured food regulatory program in Rhode Island (RI) to conform
to national standards. This program will reduce foodborne illness and injury by identifying potential
prevention practices, and will ultimately protect the public and industry by minimizing the time
between agency notification of a human food contamination event and the implementation of
effective control measures. RIDOH will continue to place an emphasis on building mutual reliance
with all programs.
The Manufactured Food Regulatory Program Standards (MFRPS) Coordinator will be responsible
for managing the grant under the direction of the Principal Investigator to maintain conformance
with the 2022 MFRPS. The MFRPS Coordinator will also manage the annual Task Force meeting
and outreach efforts to industry. All projects and work products will be shared with FDA and other
states to support the national integration effort. RI will remain actively involved in national
initiatives related to the enhancement of MFRPS and will provide continued assistance to newer
state programs that may benefit from RI’s experience.
In addition to internal auditing, RI will work with the FDA Office of Partnerships and FDA/ORA
Office of Operations Audit Staff to identify areas for improvement. During the three (3) year grant
award RIDOH will: (1) maintain a manufactured food program that is able to sustain conformance
with MFRPS and contribute to a nationally integrated food safety system (IFSS); (2) continue to
work with FDA to improve the quality of contracts, coordination of inspections, investigations and
enforcement to effectively and efficiently to protect public health to further the IFSS; (3) maintain
the manufactured food inspection and compliance program which incorporates the regulatory
framework and authority to facilitate the IFSS; (4) maintain implementation of the Preventive
Control Rule while continuing to identify and address areas of improvement; (5) maintain an
information sharing agreement with FDA; (6) continue to work with the State Laboratory and Rapid
Response team on proper MFRPS response, enforcement and regulatory framework.

Public health relevance
Project Narrative Title: Rhode Island's Maintenance of its State Manufactured Food Regulatory Program Funding Opportunity Announcement Number (FOA): RFA-FD-23-027 This grant will support the Rhode Island Department of Health’s (RIDOH) efforts to maintain a high-quality manufactured food inspection program that is based on national Standards, which ultimately will prevent foodborne illnesses from manufactured foods produced in Rhode Island. RIDOH has achieved full conformance with the 2022 Manufactured Food Regulatory Food Standards (MFRPS) and will continue to maintain full implementation under this grant. RIDOH will contribute to an integrated food safety system through mentoring and sharing best practices at a local and national level.